Project 1: Spatial imaging of whole tumor genomics to understand glioblastoma formation and evolution

PROJECT 1: PROJECT ABSTRACT
Glioblastoma (GBM) is among the most lethal and heterogeneous cancers. However, investigations of
intratumor heterogeneity, evolution, and therapeutic target selection in GBM rely on a tiny fraction of the whole
tumor. Precision therapies are therefore destined to fail if the target is heterogeneous. Conversely, tumor wide
targets likely arise in the earliest clonal expansion and should be present in most or all tumor cells. Similarly,
gene expression and epigenetic regulatory programs that are heterogeneous in a tumor may be driven by the
microenvironment or sub-clonal genetic alterations, whereas programs that are active in all tumor regions
could potentially represent the tumor’s cell lineage of origin. We hypothesize that an imaging-based tumor
wide approach will elucidate the genetic alterations of the earliest clonal expansion for each patient and the cell
lineage from which the tumor arises. The approach could also allow us to redefine tumor heterogeneity,
evolution, and target selection. To evaluate our hypothesis we will build an intratumor sample cohort from 25
newly diagnosed and 25 recurrent GBM, including patient-matched pairs. Each sample will have a 3D spatial
coordinate for mapping back into the corresponding 3-dimensional (3D) tumor representation we will create
(Aim 1). A ShinyApp will be designed for easy exploration of the data in the original context within the tumor. In
Aim 2, we will define the evolutionarily earliest tumor clone for each patient, including its genetic alterations
and the cell lineage from which the tumor arises. This will be accomplished by applying Hi-C epigenome
analysis and RNA sequencing, and other methods, to the samples from Aim 1. The assays are highly
complementary and provide comprehensive analyses of genome alterations, 3D chromatin contacts and the
gene expression programs they regulate. From preliminary profiles of 103 samples from 10 GBM patients we
discovered tumor wide genetic alterations and diverse, large scale structural variants from Hi-C data that have
a common feature – they produce gene fusions that are expressed tumor wide. We will distinguish
heterogeneous expression and gene regulatory programs from those that are tumor wide and may represent
the cell lineage of origin, as highlighted in our preliminary data. We will determine whether the tumor wide
genetic alterations and expression programs are retained over time. Heterogenous alterations and programs
will be explored for relationships with advanced imaging parameters. In Aim 3 we will determine the
transforming capacity and therapeutic value of tumor wide genetic alterations such as gene fusions that create
immunogenic neoantigens. By delineating the earliest tumor clone we will lay a foundation for human GBM cell
models that represent main root GBM cells of individual patients. Focusing on tumor wide targets will enable
development of therapeutic strategies that avoid a major source of treatment failure, broadly increasing the
opportunity for clinical impact. The data resource, The Cancer Genome Atlas equivalent for intratumor studies,
will be explorable from any computer with an internet connection.

Public health relevance
PROJECT 1: PROJECT NARRATIVE Intratumor heterogeneity underlies treatment failure in glioblastoma and is poorly understood because only a tiny fraction of the tumor is available usually. Our multi-disciplinary team will use imaging-based whole tumor sampling with genomics to delineate the roots of glioblastoma for each patient, fostering the development of better models and new therapies. The project will enable new therapeutic strategies aimed at an untapped source of therapeutic targets that could avoid the major source of failures, broadly increasing the probability of clinical impact.